Effects of androgen receptor antagonists on human T cell function

SUMMARY/ABSTRACT
The overall objective of this project is to determine how androgen receptor antagonism and other androgen
deprivation therapies used in prostate cancer affect human T cell function. Androgen deprivation is a cornerstone
of prostate cancer therapy, in which tumor cells are killed by depriving them of androgen receptor signaling, a
key growth signal. Androgens have pleiotropic effects on numerous physiological systems. In the immune
system, they are generally considered immune inhibitory and are thought to contribute to the sex differences
observed between men and women in rates of autoimmunity and cancer. Yet the effect of androgen deprivation
on T cell function in men with prostate cancer is not known. This is highly relevant to cancer treatment, because
immunotherapy in combination with androgen deprivation was recently shown to induce a durable response in
a subset of patients with metastatic prostate cancer who were progressing on androgen deprivation therapy
alone. Nonetheless, the majority of patients receiving this combination still endured cancer progression. It is
important to understand the mechanisms by which androgen deprivation affects T cell function in order to
improve combination therapy options for metastatic prostate cancer, as well as other cancers driven by androgen
receptor signaling (e.g., androgen receptor positive breast cancer).
The aims of this project are to i) determine the effect of the androgen receptor antagonist, enzalutamide, on
human T cell function in vitro, and ii) determine the effect of androgen-deprivation therapy on T cell responses
in prostate cancer patients. In aim 1, we will test the hypothesis that antagonizing androgen receptors within T
cells increases T cell proliferation and type 1 cytokine secretion and decreases establishment and/or
maintenance of T cell exhaustion. These studies will be performed using T cells isolated from peripheral blood
of healthy volunteers. T cells will be treated in vitro with the clinically relevant androgen receptor antagonist,
enzalutamide. In aim 2, we will test the hypothesis that androgen deprivation in men with prostate cancer alters
the proportions of T cell subsets, changes the transcriptional profile of T cells, and increases the magnitude of
antigen-specific T cell responses. In these studies, we will isolate T cells from peripheral blood of metastatic
prostate cancer patients collected both before and 6-12 weeks after initiation of androgen deprivation therapy.
These paired samples will allow us to clearly establish the effect of androgen deprivation therapy on T cell
phenotype and function in cancer patients. This project will reveal important information about how androgen
receptor antagonism impacts the adaptive immune response, and thus potentially alters anti-tumor immunity.

Public health relevance
PROJECT NARRATIVE Prostate cancer kills at least 30,000 Americans annually. Androgen deprivation therapy is standard treatment for metastatic prostate cancer, but the impact of this therapy on the immune system is unknown. This project aims to understand the effect of androgen deprivation therapy on immune responses, with the expectation that this information will be useful in determining how best to combine androgen deprivation therapy with immunotherapy to improve outcomes for prostate cancer patients.